Function and application of contractile injection systems and jumbophage RNA polymerases

Project Summary
The proposal contains two subprojects, each with fundamental science and application components. The first
subproject aims to build a quantitative description of the processes that take place when contractile injection
systems – phage tails, tailocins, and the type VI secretion system – breach the envelope of a bacterial cell. This
information will be used in the design and retargeting of R-type pyocins (tailocins) to medically important
pathogens. The second subproject is focused on the RNA synthesis machinery of jumbophages (i.e. very large
phages). We aim to characterize how the non-virion RNA polymerase (nvRNAP) encoded by jumbophage AR9
recognizes its promoters and how this enzyme can be used for in vitro transcription and RNA amplification.
A contractile injection system, at a minimum, consists of an outer contractile sheath, inner rigid tube, and
baseplate. The sheath and tube are fixed to each other at the baseplate-distal end. The initial, extended-sheath
conformation is a high-energy, metastable state of the system. In phages and tailocins, the baseplate carries
receptor-binding proteins, interaction of which with their cell surface ligands causes an avalanche of structural
changes: the baseplate changes it conformation, the sheath contracts and drives the tube through the cell
membrane. Recently, we have characterized the energetics of sheath contraction of the R-type pyocin using
modeling, solution biophysics, and single molecule measurements. This proposal will identify and describe the
mechanisms by which the baseplate is activated by receptor-binding proteins (tail fibers) and how the baseplate
triggers sheath contraction. The pyocins are being explored as a tunable antimicrobial platform because they
can be retargeted to a bacterial host of interest by altering their tail fibers. The quantitative description of pyocin
baseplate activation will be used to define principles for the design of hybrid tail fibers.
We have recently partially characterized how the AR9 nvRNAP recognizes its deoxyuridine-containing promoter
element in the template strand of double-stranded DNA. Structurally, this enzyme resembles a trimmed down
version of the bacterial multisubunit RNA polymerase. The enzyme contains no α or ω subunits while the slightly
shortened β and β′ subunits are encoded by two separate AR9 genes each. The AR9-encoded promoter
specificity subunit is distantly related to σ factors. Considering that other jumbophages use AR9-like RNA
polymerases for transcription of their genomes that are nearly an order of magnitude larger than the T7 genome,
the AR9 nvRNAP may represent a more powerful tool for in vitro transcription and RNA amplification than the
current gold-standard T7 RNA polymerase. We will identify the strongest AR9 nvRNAP promoters and optimal
reaction conditions to create an nvRNAP-driven in vitro transcription system. We will describe how the enzyme
recognizes promoters of different strengths in atomic detail using X-ray crystallography, cryo-electron
microscopy, and molecular dynamics simulations.

Public health relevance
Project Narrative Bacterial viruses (bacteriophages) represent an indispensable source of enzymes and biotechnological tools that have had an outsized impact on fundamental science and human health (phage T7 RNA polymerase- synthetized mRNA vaccines, CRISPR/anti-CRISPR systems, etc.). The advent of AI-driven protein structure prediction methods and advances in DNA sequencing technologies have uncovered a large amount of previously inaccessible bacteriophage-related information. The work described in this proposal will combine these innovations with established experimental methodologies to 1) describe the mechanisms by which bacteriophages recognize and attach to their host cells, 2) engineer a phage-related membrane-punching nanomachine, and 3) develop a new in vitro transcription system for mRNA-based vaccines.